Proteomics Core Facility

PCF is equipped with a Thermo Fisher Orbitrap Lumos mass spectrometer with an nanoflow Ultimate 3000 HPLC, and an Agilent 6230 LC-TOF system.

PCF seeks to provide high quality proteomics services on intact Protein molecular weight measurement; protein identification; protein quantification using label-free or labeled approaches; identification of PTMs including phosphorylation, acetylation, ubiquitination, glutamination and disulfide linkage characterization. PCF also develop methods for unique projects.

PCF staff also train users on instrument operation, educate users on mass spectrometry-based techniques, stay informed on new techniques and devices, and make them available to PCF users when possible.

In 2023, PCF supported more than 30 investigators within and outside NINDS, worked on more than 50 projects, co-authored in 5 papers which are listed below.
1) "Regulation of NLGN3 and the synaptic Rho-GEF signaling pathway by CDK5"
Jaehoon Jeong, Wenyan Han, Eunhye Hong, Saurabh Pandey, Yan Li, Wei Lu, and Katherine Roche, Journal of Neuroscience, accepted in 08-2023 Paper #JN-RM-2309-22R2

2) An iron-sulfur cluster in the zinc-binding domain of the SARS-CoV-2 helicase modulates its RNA-binding and -unwinding activities.
Maio N, Raza MK, Li Y, Zhang DL, Bollinger JM Jr, Krebs C, Rouault TA. Proc Natl Acad Sci U S A. 2023 Aug 15;120(33):e2303860120. doi: 10.1073/pnas.2303860120. Epub 2023 Aug 8.

3) The Foundational Data Initiative for Parkinson Disease: Enabling efficient translation from genetic maps to mechanism.
Bressan E, Reed X, Bansal V, Hutchins E, Cobb MM, Webb MG, Alsop E, Grenn FP, Illarionova A, Savytska N, Violich I, Broeer S, Fernandes N, Sivakumar R, Beilina A, Billingsley KJ, Berghausen J, Pantazis CB, Pitz V, Patel D, Daida K, Meechoovet B, Reiman R, Courtright-Lim A, Logemann A, Antone J, Barch M, Kitchen R, Li Y, Dalgard CL; American Genome Center; Rizzu P, Hernandez DG, Hjelm BE, Nalls M, Gibbs JR, Finkbeiner S, Cookson MR, Van Keuren-Jensen K, Craig DW, Singleton AB, Heutink P, Blauwendraat C.Cell Genom. 2023 Feb 6;3(3):100261. doi: 10.1016/j.xgen.2023.100261. eCollection 2023 Mar 8.

4) Ligand-free mitochondria-localized mutant AR-induced cytotoxicity in spinal bulbar muscular atrophy.
Feng X, Cheng XT, Zheng P, Li Y, Hakim J, Zhang SQ, Anderson SM, Linask K, Prestil R, Zou J, Sheng ZH, Blackstone C. Brain. 2023 Jan 5;146(1):278-294. doi: 10.1093/brain/awac269.PMID: 35867854

5) Combinatorial and antagonistic effects of tubulin glutamylation and glycylation on katanin microtubule severing.
Szczesna E, Zehr EA, Cummings SW, Szyk A, Mahalingan KK, Li Y, Roll-Mecak A. Dev Cell. 2022 Nov 7;57(21):2497-2513.e6. doi: 10.1016/j.devcel.2022.10.003.